Structural and Functional Characterization of the McrBC Restriction System

Abstract

Modification-­dependent restriction systems (MDRs) recognize and cleave modified foreign DNA. These
proteins are thought to play a role in establishing the epigenetic landscape of bacterial genomes and are
especially important in protecting against predatory bacteriophage viruses, many of which incorporate
modified bases into their DNA to evade detection by other defense systems. While MDRs can be found in
most antibiotic-­resistant bacteria including methicillin-­resistant Staphylococcus aureus (MRSA), Clostridium
difficile, and carbapenem-­resistant enterobacteriaceae like Klebsiella pneumoniae, no eukaryotic homologs
exist, making them promising targets for drug design. Inhibiting these systems has the potential to enhance
the efficacy of phage-­mediated bacterial killing, thus providing new therapeutic strategies to combat
persistent, antibiotic resistant microbial infections. It is our long-­term goal to study the basic biology and
mechanisms of MDRs and use this knowledge to improve current phage therapy approaches. This proposal
examines the structure and function of the McrBC restriction system, a two-­component MDR that targets
DNA containing methylated cytosines. E. coli McrB contains an N-­terminal DNA binding domain and a C-­
terminal AAA+ motor domain that hydrolyzes GTP and mediates nucleotide-­dependent oligomerization.
McrB’s basal GTPase activity is stimulated via interaction with its partner endonuclease McrC. Biochemical
studies suggest a model for DNA cleavage in which McrB and McrC assemble together at two distant
methylated sites and translocate in a manner dependent on stimulated GTP hydrolysis. Collision of these
McrBC assemblies triggers cleavage of both DNA strands. Despite this model, the molecular and
mechanistic details underlying McrBC function remain poorly defined. In Aim 1, we will dissect the species-­
specific determinants of DNA binding in different McrB homologs using X-­ray crystallography and
biochemistry. We will also generate chimeras that exchange the DNA binding domains between different
McrB homologs to test the hypothesis that the core hydrolysis and cleavage machineries in McrBC are
conserved and have adapted to different evolutionary pressures via a modular design. In Aim 2, we will use
mutagenesis and kinetic assays to identify the critical catalytic components responsible for McrC-­stimulated
GTPase activity. In Aim 3, we will determine the structure and architectural organization of the McrBC
restriction complex at atomic resolution by X-­ray crystallography and cryo-­electron microscopy. These
efforts will provide new insights into how McrBC complexes bind DNA, assemble, and hydrolyze GTP.

Public health relevance
Project Narrative McrBC is a conserved bacterial defense system that cleaves modified DNA. Our research objective is to understand the structure, function and regulation of McrBC at the molecular level, which may lead to new therapeutic tools and approaches to combat multidrug resistant bacterial infections.